B Cells: Mechanisms in Immunity and Autoimmunity

ABSTRACT Support is requested for a Keystone Symposia conference entitled B Cells: Mechanisms in Immunity and Autoimmunity, organized by Drs. Lars Nitschke, Michael Reth, Roberta Pelanda and David M. Tarlinton. The conference will be held June 17-21, 2018 at Maritim Hotel & Conference Center in Dresden, Germany B cells play an important role in immunity and immunology research. New findings about the relevance and contribution of B cells to autoimmunity have rejuvenated interest in B cell immunology research. B cell functions unrelated to the production of antibodies have also been recently uncovered, indicating B cells operate in the context of both humoral and cellular adaptive immune responses. These B cell properties have stimulated a plethora of studies aimed at discovering the molecular mechanisms of B cell development and diversification, B cell activation, B cell memory responses and B cell tolerance induction. Affinity maturation of antibodies within the germinal center is now considered to be more complex than previously thought. The generation of broadly neutralizing antibodies against viruses in a few, but not all individuals, and the generation of autoantibodies during germinal center responses, have challenged existing dogmas. B cell metabolism and its intersection with the microbiome are stimulating and exciting areas only now beginning to be explored. For example, antibody- independent functions of B cells in secreting inflammatory or regulatory cytokines, suggest B cells are relevant in many inflammatory and allergic diseases. This conference aims to address the mechanisms of B cell activation, B cell differentiation and B cell responses, and the contribution of B cells to the development of autoimmune diseases. Finally, potential new treatment options for these diseases will be covered.

Public health relevance
PROJECT NARRATIVE New findings in regards to the relevance and contribution of B cells to autoimmunity have rejuvenated interest in B cell immunology research. This conference aims to address the mechanisms of B cell activation, B cell differentiation and B cell responses, and the contribution of B cells to the development of autoimmune diseases. This conference will bring together the B cell biologists who can lay the foundations for developing new translational strategies that will target human autoimmune diseases.